INSTRUMENTATION FOR VARIOUS ELECTRON MICROSCOPES

An IBM PC/AT Clone with a 10 MHz clock and 70 Mbyte hard disk unit has been purchased along with a number of add-in cards and an expansion unit. Work is almost completed on connecting the computer to the parallel detection unit on the Hitachi 700 scanning transmission electron microscope (STEM). This will permit data acquisition for electron energy loss spectroscopy (EELS) to occur an order of magnitude faster. The next phase is to connect the computer to BEIB's Cameca microprobe to automate data collection.